Longitudinal investigation of bilingualism, executive function, and brain organization in autism

Project Summary
Autism spectrum disorder (ASD) is associated with marked heterogeneity with respect to the development of
executive function (EF) abilities. In the United States, 12 million children primarily speak a language other than
English in the home, suggesting that 1 in 4 children with ASD are being raised in a bilingual environment.
Individuals who speak two languages fluently sometimes perform better on tasks of EF than monolingual
individuals. Despite the potential advantages that bilingualism may confer, clinical practitioners commonly
advise against providing a bilingual environment for children with developmental disabilities. The rationale for
this recommendation is that concentrating on one language should better support a child’s language
development. Yet, a growing body of work suggests there are no negative effects of being raised in a bilingual
environment for children with neurodevelopmental disorders. Preliminary evidence even suggests possible
associations between bilingualism and enhanced EF in some children with ASD. Still, there is little research
specific to bilingualism in children with ASD, leaving clinicians struggling to develop informed
recommendations for families of children with the disorder. Currently, there is no developmental cognitive
neuroscience research specific to bilingualism in ASD during the critical period of early adolescence, when EF
abilities and the brain networks supporting them are rapidly maturing. This project will capitalize on data
collected as part of an ongoing project (R21HD111805) to determine longitudinal associations between
bilingualism, EF, and brain organization in ASD using behavioral and informant-report assessments combined
with state-of-the-art multimodal neuroimaging approaches. We will collect two additional time points of data
from 150 age-, IQ-, sex-, SES-, pubertal stage-, and ASD-severity matched monolingual and bilingual children
with ASD who were between the ages of 8-12 at initial study enrollment and will be between 12-16 at study
completion. The project aims to 1) determine longitudinal associations between bilingualism and EF abilities in
children with ASD using an informant-report indicator of EF, a performance-based laboratory task developed
by our lab, and NIH Toolbox Tasks of EF, 2) to determine the longitudinal impact of bilingualism on brain
functional organization underlying EF abilities in children with ASD using both task-based functional magnetic
resonance imaging and resting-state functional connectivity dynamics, and 3) to determine the longitudinal
impact of bilingualism on brain structural organization underlying EF abilities in children with ASD using
diffusion weighted imaging. The project will be conducted in Los Angeles, where nearly 60% of the population
is bilingual. This research addresses the strategic plan from the Interagency Autism Coordinating Committee
that aspires to understand alterations in brain function in ASD to better enable the development of targeted
interventions and societal accommodations that improve quality of life for individuals on the spectrum.

Public health relevance
Project Narrative Nearly 12 million children in the United States primarily speak a language other than English in the home, suggesting that 1 in 4 children with autism spectrum disorder (ASD) are being raised in a bilingual environment. The ability to speak two languages fluently may be associated with advantages outside of the language domain, including enhanced cognitive abilities over time. Understanding the cognitive and neural consequences of bilingualism in children with ASD is critical for informing clinician recommendations regarding how many languages to speak in the home.